Defining PRC1.1 as a gatekeeper of lineage plasticity and response to anti-GD2 therapy

Project Summary
Epigenetic dysregulation is frequently observed in pediatric cancers, including neuroblastoma (NB), the
most common extracranial solid tumor in pediatric patients. In my postdoctoral work, I identified that a cell state
transition from an adrenergic to a mesenchymal epigenetic state is associated with the loss of GD2 expression
and resistance to anti-GD2 therapy. Given the important role of anti-GD2 therapy in treating high-risk
neuroblastoma patients, I designed a CRISPR-Cas9 screening platform to study epigenetic regulators of GD2
expression. I identified that individual knockout of several members of the PRC1.1/BCOR complex increases
GD2 expression in GD2-low cell lines. AIM 1 will establish the relationship between the PRC1.1/BCOR complex
and GD2 regulation by rigorously testing the necessity of the PRC1.1 complex to maintain low ST8SIA1
expression in mesenchymal cell lines.
Mining genetic dependencies across 25 tumor lineages, I identified that the PRC1.1 complex is an
enriched dependency in neuroblastoma independently of its ability to regulate GD2 expression. AIM 2 will
validate that the gene PCGF1, the top enriched PRC1.1 subunit dependency in neuroblastoma, is a genetic
dependency in multiple models of neuroblastoma. I will intersect chromatin and single-cell RNA-sequencing
studies to determine the consequences of PCGF1 knockout on chromatin regulation and differentiation/cell state
trajectories.
No known small molecule inhibitors of PRC1.1 currently exist. The correlation of USP7 genetic
dependency in the Dependency Map portal against all other gene dependencies revealed a strong correlation
with PCGF1 dependency, suggesting a tractable pharmacologic approach to inhibiting PRC1.1. AIM 3 will
establish USP7 inhibition as a mechanism to modulate PRC1.1 activity. These specific aims will test the capacity
of highly potent and selective USP7 inhibitor to selectively upregulate GD2 expression and reduce
neuroblastoma viability in vitro and in vivo.
I anticipate that these findings will directly link PRC1.1 to epigenetic state and differentiation in
neuroblastoma. Moreover, it will credential USP7 inhibition as a combinatorial therapy to restore the response
to anti-GD2 therapy and directly target neuroblastoma cells. To complete the studies in this proposal, I will apply
my strong expertise in epigenetics and pharmacology. To fill in critical gaps in knowledge and expand my
scientific training, I’ve assembled a training plan that includes advisory committee members that are experts in
immuno-oncology, single-cell sequencing, and USP7 chemistry. This proposal lays a strong framework for my
long-term goal of establishing a lab that focuses on targeting epigenetic plasticity/heterogeneity as an
intervention to overcome therapeutic resistance.

Public health relevance
Project narrative Epigenetic dysregulation is frequently observed in the disease pathology of pediatric cancers, including neuroblastoma (NB), the most common extracranial solid tumor in pediatric patients. We’ve discovered that adoption of a mesenchymal lineage is associated with loss of GD2 expression, resulting in resistance to anti- GD2 therapy. This proposal outlines the targeting of PRC1.1 via inhibition of USP7 as a therapeutic intervention to directly target neuroblastomas and restore the response to anti-GD2 therapy. .